Alcohol-Related Intimate Partner Violence among Transgender and Gender Non-Conforming Adults

Project Summary/Abstract
The long-term objective of the proposed project is to determine whether (1) alcohol use temporally precedes
and increases the risk for intimate partner violence (IPV), (2) whether IPV temporally precedes and increases
the risk for alcohol use, and (3) whether proximal (e.g., trauma symptoms, gender identity discrimination) and
distal (e.g., childhood abuse, internalized transphobia) factors moderate the alcohol-IPV link among adults who
identify as transgender and gender non-conforming (TGNC). Importantly, the proposed study will utilize a daily
diary design to examine the aims and will provide the most rigorous and comprehensive assessment of the
associations between alcohol use and IPV among individuals who identify as TGNC to date.
IPV includes psychological, physical, and sexual aggression, which occur at alarmingly high rates in cisgender
intimate relationships. Rates of IPV are as high, if not higher, among TGNC adults. Moreover, IPV leads to
poor mental and physical health outcomes for victims, as well as increased health care utilization. The
proposed project will investigate the temporal relationships between alcohol use and IPV in 130 TGNC adult
drinkers. Unfortunately, there is no research on proximal and distal moderators (e.g., trauma symptoms,
childhood abuse, internalized transphobia, gender identity discrimination, TGNC-specific social support) of the
temporal relationships between alcohol use and IPV among TGNC populations. Moreover, no research has
examined the temporal relationships between alcohol use and IPV in TGNC populations.
Participants will complete brief daily surveys each day for 60 consecutive days. The daily assessments will
allow for more accurate reporting on the temporal relationship between alcohol and IPV, including proximal
moderators of this association. An integrated theoretical framework, which considers theoretical models of
alcohol-related IPV (i.e., I3) and gender minority stress, will be utilized to examine key factors which may
moderate these associations (e.g., trauma symptoms, internalized transphobia, TGNC-specific social support).
This project has the potential to provide crucial information that can be used to reduce IPV among TGNC
people.

Public health relevance
Project Narrative Intimate partner violence (IPV) among adults who identify as transgender and gender non-conforming (TGNC) is a significant public health problem. The current study will be the first to examine, among TGNC adults, (1) whether alcohol temporally increases the risk of IPV, (2) whether IPV temporally increases the risk for alcohol use, and (3) contextual (i.e., trauma symptoms, gender identity discrimination) and distal (i.e., internalized transphobia, childhood abuse) moderators of the associations between alcohol and IPV. The information obtained from this study will have direct relevance for researchers and clinicians who are interested in the reduction of alcohol-related intimate partner violence among TGNC adults.